Preclinical development of a novel antibody conjugate for intraoperative detection of pancreatic cancer

PROJECT SUMMARY
Pancreatic cancer goes undiagnosed for a number of reasons including, anatomical location, vague and non-
localizing symptoms, and a lack of adequately sensitive and specific biomarkers of disease. Combined with lack
of blood biomarkers, early detection of pancreatic cancer remains a significant challenge. Unfortunately, this
limits therapeutic strategies that are most efficacious. Consequently, approximately 20% of patients with
pancreatic cancer are eligible for curative surgery. Of those patients, approximately 75% will have recurrent
disease within the next 5 years, even those patients thought to have had negative margins. Despite the abysmal
statistics for patients with pancreatic cancer, there are now several pancreatic cancer imaging probes in
preclinical and clinical development to try to improve disease removal. Moreover, the increased use of
neoadjugant or induction thereapy has resulted in additional patients that become eligible for surgery, if they
restage at a lower stage. The opportunity to develop molecularly-targeted probes to pancreatic cancer to improve
surgery and the increased numbers of patients that may benefit from surgery are key motivating factors for this
project. Mucin-16 (MUC16) is an attractive marker for pancreatic cancer since it is highly overexpressed in
malignancies, but not inflamed or healthy pancreas. Recently, we evaluated a murine antiMUC16 antibody,
termed AR9.6, with cross-reactivity to human MUC16. In these preclinical studies, we demonstrated durable
pancreatic cancer enhancement to at least 6 days postinjectin using IRDy800-labelled AR9.6 compared to an
isotype control. Using a pancreatic cancer xenograft, AR9.6-IRDye800 was able to effectively enhance orthotopic
and metastatic disease. Metastasis detection is an added benefit because it would prevent patients from
unecessary surgery. Murine antibodies, however, are not suitable for clinical translation. Consequently, a
humanized form of AR9.6 has now been developed by our collaborative team. An Initial investigation of
IRDye800 conjugated to humanized AR9.6 suggests strong binding to MUC16 and in vivo targeting. Therefore,
the goal of this project is to perform the preclinical development of NIRF-labelled, humanized AR9.6 to
detect PDAC for improved R0 resection and to detect peritoneal metastasis. This goal will be addressed
by three specific aims: To (1) develop and evaluate humanized AR9.6-NIRF for targeting of MUC16; (2) ascertain
the preclinical contrast-enhancement and safety profile of humanized AR9.6-NIRF conjugates; and (3)
demonstrate surgical efficacy of IRDye800-AR9.6 in preclinical models of pancreatic cancer. We hypothesize
that the aberrant MUC16 overexpression in pancreatic cancer will allow specific targeting pancreatic cancer with
fluorescently labelled huAR9.6. Completion of this research project will result in a fluorescence-guided surgery
contrast agent that will be able to (1) improve the rate of R0 pancreatic cancer resections and (2) be able to
identify peritoneal metastasis, which will prevent unnecessary surgery and allow optimized treatment strategy.

Public health relevance
PROJECT NARRATIVE This project proposes the synthesis of a near infrared dye conjugated to an antibody for mucin-16 to identify tumors in the pancreas and abdominal cavity. The targeted probes will be used to help guide surgical resections of these malignancies to improve pancreatic cancer treatment or, in the case of metastasis detection, prevent patients from non-beneficial surgery with high co-morbidities and start other treatments sooner.